FDA CVM Annual Briefing with AAFCO Board of Directors

Project Summary 2020 AAFCO-FDA CVM Briefing The Association of American Feed Control Officials (AAFCO) is a voluntary membership association of state and federal agencies charged by law to regulate the sale and distribution of animal feeds and animal drug remedies. The 2020 AAFCO-FDA CVM Briefing provides an opportunity for AAFCO’s Board of Directors to meet face to face with FDA CVM staff members with whom AAFCO interacts frequently during the year as AAFCO conducts its business related to model regulations development and ingredient definitions development. AAFCO and FDA CVM have a Memorandum of Understanding (MOU) in effect until 2024 that recognizes the AAFCO ingredient definitions process, and this annual briefing is important to our two organizations to keep the lines of communication open. The AAFCO-FDA CVM Briefing offers a collaborative forum for the discussion of animal feed scientific and regulatory topics. There is no registration fee charged to cover the expenses of providing the meeting and associated travel expenses, audio/visual support, and meeting space. Attendance is typically 12 people from AAFCO’s Board of Directors as well as an additional 10 people from FDA CVM and ORA. Over the course of 3 days, the AAFCO-FDA CVM Briefing typically includes: • Discussions with top CVM officials. In 2019, Dr. Steve Solomon and Dr. Terry Schell each met with the AAFCO Directors • Updates from FDA offices. In 2019, we had an update from OTED, ORA, and other FDA offices. • The face to face format is mutually beneficial to both organizations. AAFCO intends to utilize grant funding to ensure the 2020 AAFCO-FDA CVM Briefing, which will be held in the Gaithersburg MD area, provides both the AAFCO Board of Directors and the staff we interact with at CVM with the insights we need to move forward to the benefit of the animal feed regulatory agencies, state as well as federal. After the Briefing, we provide an update to our members on the key discussion topics to keep our members informed.

Public health relevance
Project Narrative 2020 AAFCO-FDA CVM Briefing Funding from this grant will allow the Association of American Feed Control Officials (AAFCO) to meet with the staff at FDA CVM for our annual face to face meeting. This meeting will provide informative feed regulatory and scientific discussions and a collaborative forum for the discussion of regulatory issues. AAFCO and CVM have a Memorandum of Understanding (MOU) in place until 2024 in support of the AAFCO ingredient definitions process.